Asian Community-Led Health Equity Structural Intervention (Asian CHESI)

Project Summary/Abstract
Title: Asian Community-Led Health Equity Structural Intervention (Asian CHESI)
Asian Community Health Coalition (ACHC) is requesting funding for Asian CHESI, a community-
led, multisectoral partnership initiative to address structural barriers in healthcare access and
health disparities experienced by underserved diverse Asian Americans. The project will engage
ACHC coalition member organizations: over 35 Asian ethnic community/faith-based
organizations; 8 clinical providers/community health centers; 3 academic research partners with
long history of collaboration (e.g. Temple University Center for Asian Health and University of
Maryland School of Public Health); 4 health department and government affiliated agencies, and
Asian language media and legal law firm partners to plan, implement and disseminate Asian-
community-led structural interventions across U.S. Eastern region of metro Philadelphia, NJ, NYC
and DC/MD/VA. We engage this large multisectoral team of partners in a 10-year 3-Phase
process that includes intentional assessment of structural barriers, development of targeted
interventions to break-down systemic barriers, and data collection and analysis efforts to evaluate
adoption and implementation. Structural interventions will address financial, physical, language,
and cultural barriers experienced by Asian Americans and those compounded by limited
healthcare access policies, language resources, food security, community policing against anti-
Asian hate and capacity building for multilingual community health workers. Asian CHESI
specifically addresses barriers faced by Asian Americans that impact screening, monitoring, and
care of chronic health conditions (hypertension, diabetes, heart disease, and cancer), treatment
of long COVID, and access to mental health care services. After conclusion of this 10-year project,
we will have a blueprint for a multi-factor model that can be replicated in other areas with large
Asian Americans.